Estimating the impact of the school-to-prison pipeline on adolescent health: racialized,spatial disparities in policing, school discipline, substance use, and mental illness

PROJECT SUMMARY: Over 10 million students in the US attend schools with police but no counselor, nurse,
psychologist, or social worker. Yet, more than a third of the low proportion of adolescents who receive the
substance use treatment they need (6%) access it only at school; they are disproportionately Black and low-
income. Schools are thus crucial public health intervention targets for substance use and mental health
treatment, prevention, and health equity therein. But instead, many adolescents experience school as a school-
to-prison pipeline; a set of policies and practices that criminalize adolescents and ensnare them in the legal
system rather than provide support for underlying educational and developmental needs. School-based arrests
increased 300-500% and exclusionary school discipline (suspensions and expulsions) doubled over the past 40
years. Black students are more than three times as likely to be suspended or expelled as white students, all else
equal, and students removed from school are more than twice as likely to be arrested in the same month than
those not removed. Our preliminary evidence suggests that the school-to-prison pipeline is a previously
unidentified population driver of adolescent substance use and mental illness. Moreover, the pipeline coincides
with rises in aggressive community policing in schools’ surrounding communities. However, there is no research
on the public health implications of these intersecting trends. In the proposed R01, we will collaborate with the
New York City Office of School Health (OSH) to quantify relationships between aggressive community policing,
school discipline, and student substance use/mental illness in NYC. We will create a unique geocoded 2000-
2022 dataset linking all police stops/arrests; school- and student-level exclusionary discipline; restricted school-
level Youth Risk Behavior Survey (YRBS) data (e.g., tobacco, alcohol, cannabis, other drug use); and OSH’s
database of student health services records (e.g., nurse, counselor visits, referrals to mental health/substance
use treatment). We will (Aim 1) characterize direct and mediated relationships between community policing and
school discipline on school-level and (Aim 2) student-level substance use and mental health outcomes; and test
(Aim 3) whether the intensity of policing around schools modifies the relationship between school discipline and
student substance use/mental health. In all aims, we will test whether structural and institutional racism in policing
and school discipline modify hypothesized relationships. This high-impact project responds to NIDA’s interest in
improving SUD treatment for vulnerable populations in schools and the juvenile justice system, as well as
leveraging data science to improve SUD prevention. Our diverse, interdisciplinary team, led by an early-stage
investigator PI, has expertise in substance use, psychiatric, and social epidemiology; school health; the sociology
of racialized disparities in population health, education, and policing; spatial epidemiology/health geography; and
data science. Findings will be utilized by policymakers and project stakeholders (including city, state, and federal
policymakers) working to end the school-to-prison pipeline and prevent adolescent substance use/mental illness.

Public health relevance
PROJECT NARRATIVE Aggressive community policing, school discipline, and the school-to-prison pipeline criminalize adolescents and ensnare them in the legal system rather than provide support for underlying educational and developmental needs; these phenomena are a hypothesized population driver of adolescent substance use and mental illness, and racialized disparities therein. We will collaborate with the New York City Office of School Health to create unprecedented, geocoded, longitudinal data linkages between police stops/arrests; school- and student-level exclusionary discipline records; and restricted school- and student-level substance use/mental health records. We will estimate direct and mediated relationships between community policing and school discipline on school- and student-level substance use and mental health outcomes; and test whether the spatial concentration of policing around schools, as well as structural and institutional racism, modify these relationships.